C-terminal Peptide of Cardiac Troponin I for the Treatment of Diastolic Hear Failure

SUMMARY OF SUPPLEMENT RESEARCH
Calcific aortic valve disease (CAVD) is a common and severe valvular disease that causes heart failure.
Surgical valve replacement is currently the only available treatment. However, recent clinical data indicate that
the pathological myocardial remodeling and failing continue after valve replacement, severely limiting the
therapeutic effect on long-term survival. We have reported that knockout of the gene encoding calponin isoform
2 attenuates hyperchloremia-caused aortic valve calcification in ApoE knockout mice, suggesting a novel
molecular target for the treatment and prevention of CAVD. Here we propose to expand the parent research
project with new investigations into the role of calponin 2 in the pathogenesis and progression of CAVD and the
underlying mechanisms for the development of non-surgical treatment and prevention.
To further investigate the therapeutic effect of calponin 2 deletion or reduction on attenuating the
pathogenesis and progression of CAVD and to understand the underlying molecular mechanism, we shall apply
integrative multi-level approaches to pursue two supplement specific aims. Aim S1 is to characterize the
longitudinal benefit of calponin 2 deletion and reduction for mitigating CAVD and the effectiveness in
representative mouse models of different etiologies. The studies will investigate the states of disease in which
calponin 2 reduction will effectively prevent attenuate or reverse the calcific lesion of aortic valve. Aim S2 is to
understand the mechanoregulation of calponin 2 in calcific differentiation of aortic valvular interstitial cells. Aortic
valve functions in a dynamic mechanical environment. Cellular mechanoregulation plays an important role in the
pathogenesis of aortic valve calcification. Calponin 2 is a troponin-like cytoskeleton mechanoregulatory protein
that is increased in calcified human aortic valves. Among the multiple cell types involved the pathogenesis of
CAVD, we shall focus on the role of mechanoregulated functions of calponin 2 in aortic valve interstitial cells
during trans-differentiation into myofibroblasts and osteogenic cells. The studies will learn mechanistic insights
into the development of calponin 2-targeted treatment and prevention of CAVD in the context of valvular
hemodynamics and pathological tissue remodeling.
This supplement research is proposed on the basis of strong scientific premise and prior research,
innovative molecular targets, testable hypothesis and multi-level integrative experimental systems. The
anticipated results will have major scientific and medical implications. With demonstrated expertise in calponin
research and in collaboration with CAVD expert, our productive team of investigators has all necessary technical
capacities, methodology and tools, and mouse models to launch the new studies and make timely progresses
to develop a more comprehensive research program toward translation into new non-surgical treatment and
prevention of CAVD.

Public health relevance
NARRATIVE OF SUPPLEMENT RESEARCH Calcific aortic valve disease (CAVD) is a common and severe valvular disease that causes heart failure even after valve replacement. Based on a novel finding in the PI’s laboratory, the supplement research investigates the role of calponin 2 in the pathogenesis and progression of CAVD. The new studies will characterize a promising molecular target and mechanism for the development of much needed medical treatment and prevention of CAVD.